Mechanisms of STING-driven autoinflammation

Cyclic GMP-AMP synthase (cGAS) detects foreign DNA during infection or self-DNA leading to
autoinflammatory diseases such as Aicardi-Goutieres syndrome. cGAS signals via STING, a receptor for cyclic
GMP-AMP generated by cGAS. A series of gain-of-function mutations resulting in constitutive activation of
STING have been associated with a debilitating autoinflammatory disease called STING-Associated-
Vasculopathy with onset in Infancy (SAVI). SAVI patients suffer from severe vasculitic lesions and interstitial
lung disease (ILD) and frequently succumb to respiratory failure. Like the lung conditions associated with other
autoimmune diseases such as rheumatoid arthritis and systemic sclerosis, very little is known about the
mechanisms that promote inflammation in these patients. To gain insights into the mechanisms of STING driven
inflammation in the lung, we have developed a murine model for the most common SAVI mutation, STINGV154M
(VM), and found that mice heterozygous for this mutation develop immune abnormalities and lung disease. Lung
endothelial cells are among the highest STING-expressing cells in the lung and based on our preliminary data
we believe that auto-inflammation in the VM lung results from the direct effects of the SAVI mutation on “initiator”
radioresistant cells (endothelial cells, and/or fibroblasts) resulting in stromal cell activation, differentiation,
chemokine production and expansion. Lymphocytes (VM or WT) are then recruited to the lung. The recruited
effector T cells further promote the pathogenic activity of both radioresistant cells and myeloid cells, leading to
chronic inflammation; IFN plays a key role in this process. How the VM SAVI allele mediate disease
pathogenesis in stromal cells remains unknown. We will focus on STING activation in endothelial cells and how
these events lead to lymphocyte recruitment, activation and pathology. Aim 1 will determine the lymphocyte-
independent effect of SAVI mutations on lung innate immune function. Aim 2 will define the role of infiltrating T
cells in the development of VM ILD while Aim 3 will define VM-driven signaling events in ECs and the impact of
STING-targeted therapeutics on ILD. There is an urgent need to identify better therapies for patients afflicted
with autoimmune and autoinflammatory lung disorders and the studies proposed in this application should
provide critical insights that will enable us to design the best therapies. Further, these studies will also provide
an opportunity to study the impact of STING activation on stromal cell types more generally, an emerging area
of research as STING activity in endothelial cells has recently been linked to the development of severe
COVID19.

Public health relevance
NARRATIVE Autoimmune and autoinflammatory diseases afflict 7-9% of the world population, and the goal of this project is to understand how the cytosolic cGAS/STING DNA sensing pathways contributes to these potentially devastating diseases so that we can better control them. This project draws on investigators with complementary expertise and will apply exciting new tools and strategies to study how innate immune responses in non-hematopoietic cells can promote lung complications. Insights resulting from this project should give us an opportunity to develop better treatment strategies for the many patients who suffer from interstitial lung disease.